Training in Pediatric Gastroenterology and Nutrition

PROJECT SUMMARY:
The overarching goal of our Training Program is to prepare MD, MD/PhD pediatricians, and PhD
scientists for careers in independent research on topics relevant to digestive diseases in infancy,
childhood, and adult life. The rationale for our program is founded upon the idea that meaningful and
strong intellectual, mentoring, and financial support for newly emerging scientists will enable the
recruitment of talented young people to our field, and foster early success in their long-term career
development as effective independent investigators pursuing meaningful science relevant to health and
disease of the alimentary tract. We offer training in 4 broad areas relevant to our field of gastroenterology:
* Epithelial Cell and Molecular Biology - including Stem Cell/Developmental Biology and Enteric
Neurobiology * Innate and Adaptive Mucosal Immunology; * Microbial Pathogenesis, Gut Microbiome,
and effects on Metabolism; and * Clinical Research. The training program provides an in-depth
comprehensive and strongly mentored scientific experience for each trainee in a research group at the
forefront of its field. Eight postdoctoral positions are requested. 37 NIH-funded highly-accomplished core
reseach faculty support this effort, providing great depth and diversity of scientific training and over $49
million in combined current research support. Opportunities for cross-fertilization among faculty members
and their trainees are abundant.
The Program Director is Dr. Wayne I. Lencer MD, Longwood Professor of Pediatrics, Harvard
Medical School, and a widely respected investigator and mentor. Program steering committee includes
Drs. Scott Snapper MD PhD, Rachel Rosen MD MPH and Jon Kagan PhD. An External Advisory Board
and an additional invited outside reviewer provide oversight to the program. Scholarship Oversight
Committees (SOCs) are assembled for each trainee to provide oversight (and further mentoring) in
personal scientific and career development. Didactic course work is encouraged for both basic and
clinical research training and supplemented with relevant seminars and journal clubs, a course in the
responsible conduct of research, and an annual research retreat. For clinical research trainees, the
program supports matriculation trough a Master’s Degree in Medical Science or Public Heath (MMSc or
MPH) from Harvard Medical School or Harvard School of Public Health.
Since 1997, 88% of our past 89 Trainees remain in academics, 6% in industry, 2% in government
(NIH/FDA), and 2% are in clinical practice. 21% of our past Trainees have achieved independent research
awards (RO1 or equivalent) and 62% have achieved additional career development awards (NIH K-series
and F-series and equivalent). Our program has populated the faculty of academic institutions across the
nation and internationally.

Public health relevance
PROJECT NARRATIVE: The goal of this application is to prepare MD, MD/PhD pediatricians, and PhD basic scientists for careers in independent research on topics relevant to digestive diseases in infancy, childhood, and adult life. Post-doctoral training in both basic and clinical research relevant to the GI tract is provided.